Role of Pancreatic Elastase in Beta Cell Health, Autoimmunity and Type 1 Diabetes

PROJECT SUMMARY/ABSTRACT:
The exocrine (e.g., acinar cell) and endocrine (e.g., islet b-cell) compartments of the pancreas have long been
considered functionally distinct. However, there is now overwhelming evidence for exocrine-endocrine crosstalk
in the development, physiology, and dysfunction of the pancreas. For example, pancreas size (99% of which is
exocrine tissue) is significantly reduced at type 1 diabetes (T1D) onset, in islet autoantibody-positive donors
without diabetes, and in first degree relatives of T1D patients
elements for exocrine-specific digestive enzymes
pathogenesis, but mechanisms remain unknown. In response to RFA-DK-23-007, our Team brings deep
. Multiple T1D risk variants map to cis- regulatory
. These findings implicate the exocrine pancreas in T1D
expertise in the biology, immunology and imaging of the exocrine/endocrine pancreas to unravel the molecular
crosstalk among these cellular compartments in b-cell health and immunity.
Our Team recently discovered that unregulated pancreatic elastase activity from acinar cells has detrimental
effects on b-cell biology and immunity. Mechanistically, we have evidence that elevated pancreatic elastase
proteolytically inactivates a cell surface growth receptor on b-cells to trigger a signaling cascade that halts
proliferation, increases inflammatory cytokines, and leads to cell death. Furthermore, our Team discovered a
missense mutation in pancreatic elastase that increases its expression and is linked to an inherited syndrome of
pancreatitis, diabetes and pancreatic ductal adenocarcinoma. In parallel, we have identified small molecules that
inhibit pancreatic elastase expression or activity, increase regulatory T-cell numbers in vivo, and promote murine
and human b-cell health to prevent diabetes in mice.
Taken together, our preliminary data support the over-arching hypothesis that elevated pancreatic elastase
activity is directly pathogenic to islet b-cells in part through impairing growth signaling to induce secretion of
inflammatory cytokines, autoimmunity and cell death; and that attenuating elastase activity will promote b-cell
health and protect against T1D. Building upon these results, the goals of this project are to determine the human
T1D relevance of the pancreatic elastase signaling circuit by defining how it: (1) predicts T1D risk in patients, (2)
triggers inflammation and autoimmunity, and (3) can be effectively targeted to prevent and/or reverse T1D.
These studies will provide insights into the mechanisms responsible for pancreatic exocrine-endocrine crosstalk
in T1D by understanding how pancreatic elastase impacts human b-cell health and autoimmunity, and test new
pharmacologic approaches to limit elastase activity as a novel therapeutic strategy for T1D.

Public health relevance
PROJECT NARRATIVE The pancreas has long been viewed as an “twin organ” made up of two distinct cellular neighborhoods that function independently—(1) exocrine cells that produce digestive enzymes to help breakdown our food and (2) endocrine cells that produce insulin to control blood sugar. However, recent evidence from our team and others strongly argues that certain digestive enzymes made by exocrine cells, especially one called pancreatic elastase, are harmful to insulin producing endocrine cells and promote the development of type 1 diabetes. Building upon these pioneering results, the goals of this project are to determine how pancreatic elastase: (1) damages insulin producing endocrine cells, (2) triggers inflammation and autoimmunity against these cells, and (3) can be effectively targeted to prevent and/or reverse type 1 diabetes.